PHASE III CLINICAL STUDY OF HYPERIMMUNE ANTI HIVIG PREVENTION OF AIDS IN INFANTS

To determine if giving HIVIG to pregnant HIV infected women taking AZT can lower the chance for their babies to get HIV from their mothers.